Ultrathin dissolvable antibiofilm wound contact dressing with silver and gallium

The entire Research Plan contains proprietary/privileged information that Imbed Biosciences requests not be released to persons
outside the Government, except for purposes of review and evaluation.
SUMMARY
The health care costs associated with treatment of chronic wounds exceeds $25 billion annually in the U.S.
Biofilms are implicated as a key factor responsible for delayed healing. Many wounds have complex surfaces
and debridement can be challenging, leaving biofilm fragments that remain resistant to antimicrobial therapy and
act as a nidus for recrudescence of biofilms. There is no commercially available topical formulation effective in
dispersal of biofilms in wounds. Research at Imbed Biosciences, funded by NIH and private equity investments,
has resulted in the development of an ultrathin wound contact matrix with a unique form factor. Microlyte® Matrix
is a 20-25 µm-thick bioresorbable polymeric multilayer film that allows painless placement in wounds and can
be engineered to dissolve over several days. The ultrathin matrix conforms intimately to the underlying contours
of a wound bed to provide localized and long-term release of bioactive molecules. Imbed recently obtained FDA
clearance for Microlyte® Ag wound matrix based on that platform, where the matrix was impregnated with silver
nanoparticles formed in situ. It has been used successfully to heal chronic wounds in thousands of patients in
U.S. It is effective in killing a broad spectrum of bacteria in vitro and in infected wound models in mice. However,
it is not effective in killing bacteria encased in biofilms. In our recently published study, we demonstrated synergy
of silver and gallium (Ga3+) ions in eliminating biofilms. Based on those scientific findings and successful clinical
adoption of Microlyte® Ag matrix ultrathin form factor in hospitals, objective of this SBIR project is to develop an
economic, easy to place, dissolvable wound contact matrix that can deploy synergy of silver and gallium on a
wound surface to eliminate biofilms. Year 1 of Phase 2 research identified 10 µg/cm2 silver nanoparticles and
140 or 210 µg/cm2 gallium as optimal biocompatible loadings for Microlyte Matrix and showed that these
prototypes- (1) provided > 4 log10 CFU reduction in 48 h old mature biofilms of P. aeruginosa in vitro and > 3
log10 CFU reduction in a mice wound model, and (2) were biocompatible in accordance to ISO 10993 guidelines.
These results proved our scientific premise of amplifying synergy in pairing gallium and silver ions against biofilm
bacteria by presenting them in a microscale matrix. Completion of Phase II research in Year 2 will result in
finalizing one a biocompatible prototype that is effective in killing multispecies biofilm in porcine wound models
and accelerate healing. Based on our FDA pre-sub meeting, this CRP research proposal aims to establish quality
controls, validate the product design, fabrication process, set up e-beam sterilization protocol and collect GLP
preclinical performance data on product manufactured under quality control, for accelerate an FDA 510k de Novo
application. For this project, Imbed has assembled a team of researchers with substantial expertise in
biomaterials (Agarwal, Pranami, Dalsin, and Abbott), microbiology (Czuprynski), animal wound models
(McAnulty) and clinical wound care (McAnulty and Schurr).

Public health relevance
NARRATIVE Wound management presents a huge economic and healthcare burden in the U.S. The research described in this SBIR application will lead to the realization of a new form factor for wound management: an ultrathin dissolvable matrix that synergistically combines the benefits of antimicrobial and antibiofilm agents to aid wound-bed preparation. The new wound matrix will adhere intimately to the contours of wound-bed, allow moist wound healing, and kill bacteria in biofilms hiding in crevices of wound tissue surface. It will reduce the frequency of surgical debridement in chronic wounds by eliminating fragments of biofilms harboring in wound-bed, the breaking the cycle of microbial recrudence in chronic wounds. Adoption of this new antibiofilm matrix in work flow of clinical wound management may expedite wound closure, reduce use of antibiotics, reduce nursing time, lower patient pain, reduce length of hospital stays, and reduce overall wound treatment costs.